Improving Brain Recovery Through Glycoengineering

Project Summary
This project is based on recent advances in metabolic glycoengineering (MGE), a technology platform where
non-natural monosaccharides intercept the biosynthetic pathways for cell surface-displayed glycans. As a
result, chemical functionalities not naturally found in carbohydrates are installed in the glycalyx, which can alter
cell adhesion, receptor activity, and downstream events (e.g., apoptosis, differentiation, and motility). In
previous work, we developed the N-acetylmannosamine (ManNAc) analog “Ac5ManNTGc” to install thiol
groups into sialic acids in human embryonic cells and found that – when the cells were grown on a “high affinity”
surface (e.g., gold, which forms coordinate covalent bonds with thiols) – Wnt signaling was upregulated in the
absence of extracellular Wnt proteins and neuronal differentiation was induced. In vivo translation of this
approach, however, was hindered by the requirement for a non-degradable gold scaffold. We recently
overcame this impediment by designing new ManNAc analogs with thiols presented on longer linkers, which
extends this functional group further away from the core monosccharide and increases analog potency.
Critically, the new analogs provide pro-neurogenic activity in the absence of a scaffold thereby simplifying in
vivo translation. This project will explore analog mechanism in hNSCs in Specific Aim 1; this aim will define
how the chemical structure, kinetics, and dose of thiol-modified ManNAc analogs (along with chemically inert
size-matched controls) modulate cellular glycans in Aim 1a; evaluate changes to cell adhesion and motility in
Aim 1b, and evaluate the differentiation of human neural stem cells (hNSCs) in Aim 1c. Next, in Specific Aim
2, we will apply the optimized analog-treatment conditions to improve neural regeneration in a rat cardiac
arrest (CA) model of brain injury by transplanting MGE-modified into injured animals. We will compare hNSCs
treated with our new thiol-modified analogs with appropriate controls on functional recovery after CA by
evaluating survival, adhesion, distribution, and migration of transplanted hNSCs in rat brain. In Specific Aim 3,
we will evaluate biochemical (Wnt signaling and cadherin involvement) and cellular (tissue infiltrating immune
cells) level mechanisms we propose contribute to the healing effects of MGE in brain injury recovery (in Aim
3a). Finally, in Aim 3b we will characterize cell-wide “glycosites” by mass spectrometry and use
glycobioinformatics analyses to identify unknown biochemical mediators of MGE. Specifically, we anticipate
identifying new mediators of the beneficial effects of MGE in the implanted hNSCs as well as trans-acting host
proteins. We hypothesize that thio-analogs modulate hNSC fate through a complex combination of receptor-
specific effects on cell signaling and adhesion providing a pleiotropic suite of healing effects that cannot be
achieved through conventional therapies. Accordingly, our innovative approach opens a new avenue to
improve stem cell therapy with our new thiol-based MGE technique.

Public health relevance
Project Narrative This project exploits a technology platform that modulates the activities and functions of neural stem cells by biochemically engineering their cell surface carbohydrates. We apply this “metabolic glycoengineering” strategy to promote neural regeneration to heal brain injury in a rodent model and investigate the mechanistic basis of the anticipated healing effects.